Novel cysteinyl leukotriene receptor signaling in regulating cellular, and molecular events in lung inflammation

Project summary:
Cysteinyl leukotrienes (cys-LTs; LTC4, LTD4, and LTE4) play an important role in asthma, allergy, and
inflammatory bowel diseases via their receptors, CysLT1R and CysLT2R. However, the role of cys-LTs in
regulating the inflammatory and proliferative phenotypes of macrophages (MФ) or their role in MФ-mediated lung
inflammation is not well defined. Our preliminary work revealed a previously unidentified role for CysLT1R in
balancing MФs’ inflammatory potential, metabolic function, and proliferation in vitro, and a role in driving LPS-
mediated lung inflammation in vivo. Based on these findings, we hypothesize that the presence of CysLT1R
drives the inflammatory state of MФs and lung inflammation in response to LPS. Further, since CysLT1R and
CysLT2R antagonize each other, CysLT1R may act as a molecular brake for MФ hyper-proliferation via binding
to and inhibiting CysLT2R. We propose to test this hypothesis in three aims. In Aim 1, we will determine the
mechanistic aspects of how CysLT1R promotes the hyper-inflammatory MФ phenotype in vitro and analyze how
CysLT1R influences the resident and recruited immune population in the lung in response to acute lung injury
(ALI). In Aim 2, we will elucidate how CysLT1R suppresses MФ proliferation, and metabolism, and we will explore
its antagonism towards CysLT2R in deciding the MФ activation state. Finally, in Aim 3, we will determine the
pathophysiological significance of myeloid CysLT1R signaling in mediating lung inflammation in murine ALI
models. Further, we will explore the therapeutic potential of blocking CysLT1R using MK571/Singulair, an FDA-
approved asthma drug. Although a few reports have suggested the benefits of Singulair in reducing pulmonary
inflammation during LPS-ALI and COVID-19, neither the mechanistic aspects, nor its prophylaxis vs therapeutic
effect on all ALI parameters, were previously addressed. The successful completion of our project will unravel
the previously unknown unique roles of CysLTR in influencing MФ function and its role in lung
inflammation/injury.

Public health relevance
Project Narrative This proposal seeks to determine how inflammatory lipid receptors CysLTR, fine tune the signaling outcomes in macrophages by LPS, leading to amplification of pulmonary inflammation. Identifying these signals will help us in a better understanding of macrophage-mediated cytokine storm during inflammation and identify novel treatment strategies for acute lung injury (ALI) and other inflammatory diseases involving macrophages.